Biophysical determinants of chemotaxis in Helicobacter pylori

Project Abstract
Infections by the motile bacterial species, Helicobacter pylori, are promoted by chemotaxis, which
refers to the ability to migrate towards favorable chemical environments. H. pylori infections are a major cause
of peptic ulcers and gastric cancers. Yet, the biophysical mechanisms of chemotaxis in H. pylori are not
understood. In the canonical chemotaxis network, chemoreceptors sense extracellular ligands and regulate the
activity of a chemotaxis kinase. The kinase in turn modulates flagellar functions to bias bacterial migration. To
prevent the network from desensitizing upon ligand-detection, two enzymes, CheR and CheB, continuously
reset the kinase activity. Such resetting (adaptation) increases the dynamic range of ligand sensing in the
network, without which the cell cannot continue migrating up or down chemical gradients. However, H. pylori
lack CheR and CheB homologues. Also, the pattern of motility in H. pylori is different from the standard model,
Escherichia coli, since H. pylori localize all their flagella at a single pole – individual cells swim forward (run)
and backward (reverse), rather than running and tumbling as E. coli do. This subtle difference in motility is
predicted to give rise to multiple chemotaxis errors in the canonical framework. Hence, current mechanistic
models of chemotaxis are unable to explain biased and error-free migration in H. pylori. Without a fundamental
understanding of chemotaxis in H. pylori, the development of antibacterials that target chemotaxis will likely
remain limited. In the proposed work, the PI’s primary goal is to explain how the chemotaxis network
modulates flagellar functions to promote chemotaxis in H. pylori. The PI’s long term goal is to use the insights
from the proposed work to develop innovative methods to prevent H. pylori infections by inhibiting chemotaxis.
The PI will make use of a novel technique that overcomes the status quo by allowing quantification of flagellar
functions without probing individual flagellar motors. Through a combination of optical tweezers, phase
microscopy, and stochastic modeling, the PI will determine how chemotaxis errors are prevented at a single
cell and population level in H. pylori. The team will pioneer the development of novel assays, including a FRET
assay, to experimentally measure chemotaxis signaling in H. pylori. The PI will also determine the role of key
coupling proteins that have been hypothesized to play a major role in chemotaxis adaptation. In addition to
establishing the biophysical principles of chemotaxis in H. pylori, the following payoffs are anticipated: 1) a
paradigm will be established for understanding chemotaxis migration in other run-reversing species, 2) novel
mechanisms of chemotaxis adaptation are likely to be elucidated, 3. a FRET-based assay will be developed,
which will significantly boost current efforts in the field to understand chemoreceptor functions and chemotaxis
signaling mechanisms in H. pylori. Successful execution of the projects will enable a major advance since
chemotaxis strategies remain poorly understood in a large majority of bacterial species.

Public health relevance
Narrative The proposed research is expected to explain the biophysical principles by which Helicobacter pylori, which cause gastric cancers and peptic ulcers, migrate towards favorable chemical habitats to establish colonies. In the proposed work, we will pioneer the use of novel biophysical methods to determine the molecular mechanisms of bacterial migration. Fundamental insights from our work will likely help develop novel strategies to prevent H. pylori infections of the stomach.